Hazardous Materials Worker Health and Safety Training (U45), Cooperative Agreement

Project Summary
Since 1987, The New England Consortium-Civil Service Employees Association (TNEC-CSEA)
has been providing participatory hands-on HAZWOPER training and disaster preparedness
training to workers throughout the New England region and New York State. TNEC New
England's previous experience in disaster preparedness training includes: training for
municipalities beginning in 2006, after Hurricane Katrina and after the 2006 Mother's Day
flooding in the Merrimack Valley region, and continuing to the present in collaboration with
Massachusetts Interlocal Insurance Association, and working with numerous municipalities
throughout the region, in the form of 4-6 hour disaster preparedness courses; through
supplemental funding in 2016-17, 4-6 hour disaster preparedness training for municipalities and
state agencies in Massachusetts; throughout the COVID-19 pandemic, 2-3-hour online/virtual
disaster preparedness training for community organizations, volunteers, local public health
departments, and citizens. In addition, TNEC/New England's previous experience in infectious
disease training in 2008-09 (avian flu), 2014 (Ebola), and 2020-2023 (COVID-19). TNEC-CSEA
supported recovery centers in eastern Massachusetts (MassCOSH) and the Naugatuck Valley
region of Connecticut (CTCOSH) in 2021-23, and in 2022-23 with the Lowell Community Health
Center and the Coalition for a Better Acre (Lowell, MA). TNEC-CSEA's proposed program has
four (4) principle components: 1) a partnership with the Lowell Community Health Center in
Lowell, MA, to train community health workers and community residents on Disaster
Preparedness, Infectious Disease Awareness, and CPR/First Aid; 2) a partnership with the
Coalition for a Better Acre in Lowell, MA, to support and expand their disaster preparedness and
infectious disease training programs for community members, non-profit workers, and CBA's
staff; 3) an expansion of MassCOSH's partnership with the Massachusetts Association of
Community Health Workers to provide training and support on disaster preparedness, and
continue and expand MassCOSH's disaster preparedness related training, through community
partners, for a variety of vulnerable workers throughout Massachusetts; and, 4) TNEC New
England would conduct 4-hour Disaster Preparedness courses, to be offered asynchronously
and in-person/virtual, as well as 8-hour Disaster Preparedness and 15-hour Disaster Site
Worker in-person courses, all for community, environmental justice, and volunteer organizations
in Massachusetts and Rhode Island.

Public health relevance
This proposal will enhance public health and reduce illness/disabilities by training community health workers, non-profit staff and community residents on Disaster Preparedness, Infectious Disease Awareness, and CPR/First Aid in asynchronously and in-person/virtual formats.